Emerging methods and applications for test-negative studies of of infectious disease interventions

PROJECT SUMMARY/ABSTRACT
The need for longitudinal follow-up of individuals exposed to interventions against rare
infectious disease endpoints poses a barrier to prospective efficacy and effectiveness studies.
Studies using the test-negative design (TND) have become a popular alternative. TNDs
represent a variant on traditional case-control designs: studies enroll subjects who seek care for
a clinical syndrome, defining those who test positive and negative for a pathogen of interest as
“cases” and “controls”, respectively. To facilitate rigorous and reproducible assessments of
vaccine performance, the project will re-assess emerging applications of the TND, and
contribute methods to measure intervention effects from data collected by TND studies.
The first two aims revisit estimation strategies for vaccine-conferred protection against infection
and against the progression of infection to disease—the two components of the vaccine “direct
effect” that TND studies aim to measure. We propose novel frameworks to estimate each effect
through extensions of the TND: one through comparisons of symptomatic and asymptomatic
persons, and another leveraging the age distribution of cases. We will apply these methods to
estimate pneumococcal conjugate vaccine effectiveness against vaccine-serotype pneumococcal
pneumonia and carriage, and to re-assess reported differences in rotavirus vaccine effectiveness
across high, middle, and low-income countries.
In Aim 3, we will continue development of statistical procedures for cluster randomized test-
negative designs. A major field trial of this nature for a vector intervention utilizing the
bacterium Wolbachia to reduce dengue fever transmission is nearing completion. Permutation-
based inference is planned because of small numbers of clusters. We will extend such methods
(i) to allow for individual measures of intervention exposure (based on human and mosquito
mobility), and (ii) to include design variants such as the stepped wedge design and interrupted
time series where data collection has either recently ended or is in process. We will also consider
a novel application to assess a new vaccine against Ebola Virus Disease (EVD) in the
Democratic Republic of the Congo. This project will thus contribute methods and computational
routines to allow valid inferences from TND study data, permitting novel assessments of
interventions against rotavirus, pneumococcal disease, EVD, and dengue etc.

Public health relevance
There is a demonstrated need for practical and functional designs to assess the effectiveness of interventions against infectious disease endpoints, and the test-negative design (TND) presents such an opportunity. This proposal tackles challenges to the validity of the TND, given that it is widely used now in studies of influenza, rotavirus, cholera, Ebola Virus Disease (EVD), and other pathogens, and considers extensions to interventions that are implemented at a community or clustered level. The results will contribute methods and computational methods to improve researchers’ ability to make valid inferences from TND data, together with novel assessments of interventions against pneumococcal disease, rotavirus, EVD, and dengue.